Development of a novel, noninvasive, sensitive measure of retinal dysfunction

PROJECT SUMMARY/ABSTRACT
Retinal diseases such as diabetic retinopathy affect >100 million world-wide, and detection of retinal dysfunction
is often delayed due to the paucity of scalable early diagnostics. This predicament is problematic, as patient
outcomes are improved with early detection. Early diagnosis of diabetic retinopathy before patients develop
visual symptoms offers opportunities to treat hyperglycemia and prevent vision loss. While diabetic retinopathy
preferentially affects the inner retina as determined by electroretinogram (ERG), other diseases such as retinitis
pigmentosa (RP) affect the photoreceptors in the outer retina. Clinically, photoreceptor degeneration can
advance without reducing visual acuity below normal limits until the majority of foveal cones are lost. This
shortcoming has been validated by adaptive optics scanning laser ophthalmoscopy (AOSLO) to compare cone
densities with the results of conventional localized measures of visual function, including visual acuity and
macular sensitivity in patients with RP. While ERG and AOSLO are sensitive enough to detect the earliest signs
of diabetic retinopathy and RP, respectively, they are not widely available as standard of care, and identifying
additional sensitive and simple tests would facilitate earlier diagnosis and also accelerate the progress of clinical
trials of new treatments, where more precise outcome measures are required to evaluate safety and efficacy.
Thus, there is a critical need for the invention of new highly sensitive, scalable diagnostics for retinal dysfunction.
This proposal aims to develop a scalable, sensitive diagnostic method for clinical measurement of retinal
dysfunction with improved sensitivity over the current standard of care. The motivation for this pursuit comes
from our preliminary data showing that graded cone loss can be detected in mice by measuring a highly-
conserved, visually-evoked compensatory behavior known as the optokinetic reflex (OKR). The goal is to expand
this methodology to the clinic for the detection and monitoring of localized cone and inner retinal function. To
achieve this goal, we will develop OKR-inducing stimuli that are optimized to probe graded macular function in
humans and compare OKR responses with structural measures of cones using AOSLO and functional measures
using ERG in control subjects and in (Aim 1) RP patients and (Aim 2) diabetic patients. Our central hypothesis
is that OKR gain (i.e., eye movement relative to stimulus movement) will be modulated with photoreceptor
density, regularity, and inner retinal function. The rationale for developing an approach to interrogate cone
densities and inner retinal function includes that (1) such a test would provide more sensitive measures of cone
survival compared to visual acuity, which is the current standard, and (2) early intervention could preserve critical
elements of human vision, including high-acuity foveal vision. Completion of this project would yield critical tools
for improving diagnosis of retinal dysfunction and the monitoring of disease progression. Such advances would
not only tangibly deliver improved patient outcome measures, but also open the opportunity for early intervention
via a multitude of developing therapeutics.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will yield critical tools for improving diagnosis of retinitis pigmentosa, diabetic retinopathy, and the monitoring of disease progression. Such advances would not only tangibly improve patient outcomes, but also open the opportunity for early intervention via a multitude of developing therapeutics for retinal dysfunction.